HIV and Other Infectious Consequences of Substance Abuse

PROGRAM SUMMARY/ABSTRACT
T32DA013911, HIV and Other Infectious Consequences of Substance Abuse, has been training fellows
for over 20 years. The training program entered a no-cost extension period on July 1, 2022 as we now await
the disposition of our competitive renewal application submitted earlier this year. This supplement requests
support for three one-year training slots to support exceptional post-doctoral research fellows. The
overall theme of the parent training program is community-engaged clinical research on HIV and other
infectious diseases within the context of the substance use epidemic. One of the most important strengths
of this program is its into a trans-disciplinary collaboration between substance use science, HIV medicine and
other infectious diseases (Hepatitis B/C, STDs, and TB), other medical disciplines, behavioral sciences, and
epidemiology, and biostatistics. We have three exceptional scholars, two of whom are currently engaged in their
first year of this training program.

Public health relevance
PROJECT NARRATIVE T32DA013911, HIV and Other Infectious Consequences of Substance Abuse, has been training fellows for over 20 years. One of the most important strengths of this program is its into a trans-disciplinary collaboration between substance use science, HIV medicine and other infectious diseases (Hepatitis B/C, STDs, and TB), other medical disciplines, behavioral sciences, and epidemiology, and biostatistics. .